Administrative Core: 3D Models of Engineered Human iPS Cells to Investigate Neurotropic Virus Infections

The Administrative Core of the MIT Center for Human Tissue Models of Infectious Diseases (MIT.HTMID) will be the organizational center for research, administration, and outreach. The Administrative Core, led by Dr. Gehrke, will coordinate, supervise, and manage all MIT.HTMID financial and research activities to achieve the Center’s goals. The Administrative Core principal staff member (Administrative Officer, AO) will be a key member of the Center’s staff who will be expected to bring expertise and problem solving skills to the group. The Administrative Core will serve the day­to­day needs of the three investigators and their laboratories by supporting appointments, facilitating the purchase of materials and supplies, coordinating communications among the investigators and their laboratories, as well as communications with NIH and other HTMID CRCs. The Administrative Core will seek ?to promote communication, collaboration and coordination among the investigators, laboratory personnel, Cores, and NIAID staff, including the NIAID Project Scientist, Program Officer, or other staff. The Administrative core will also assist Core Leaders and investigators with administrative aspects of their projects, such as doing spending projections, gathering of annual progress reports, and facilitating other communications with awardees and their mentors. Through the leadership and initiative of the Administrative Core, the MIT.HTMID Center will ?foster outreach activities to promote collaborations with the pertinent scientific communities. These activities could be seminars, workshops, or short courses. The Administrative Core will also administer Pilot Developmental Research projects that will sponsor short­term seed projects to encourage improvements in Human Tissue Engineering Technology that will be incorporated into the human cerebral organoid model. The Administrative Core will be a critical element of the successful MIT.HTMID Center, and through it, Dr. Gehrke and the AO will set the tone of the Center to establish the supportive structure required for the Center to accomplish all CRC goals.